Intervention to Help Orient Men to Excel (IN-HOME): A culturally appropriate CHW training program to reduce minority caregiver burden

KDH Research & Communication (KDHRC) submits this proposal to expand and fully evaluate the
Intervention to Help Orient Men to Excel (IN-HOME). IN-HOME is a culturally competent, online professional
development course to prepare community health workers (CHWs) to conduct outreach to reduce informal
caregiver burden, with a specific focus on supporting Black and Latino male caregivers of older adults (aged
65+) who are aging in place. The IN-HOME model has two stages. In stage one, the training course increases
CHWs’ knowledge, skills, and perceived self-efficacy to conduct outreach to Black and Latino male caregivers.
In stage two, IN-HOME-trained CHWs support Black and Latino male caregivers, and through their
interactions, build caregivers’ knowledge, positive attitudes, self-efficacy, and intentions around self-care, their
health, and caregiving topics.
Our Phase I efforts resulted in a dynamic prototype CHW training course that significantly increased
CHWs’ abilities to conduct successful outreach. KDHRC enters the Phase II proposal with a solid prototype,
strong feasibility results, pending publications, and an outstanding team of collaborators, consultants,
contractors, and expert advisors. Phase II IN-HOME CHW training finalizations plans include adding training
lessons, developing additional interactive content, and filming video vignettes. A toolbox app will create a
technology that facilitates private synchronous and asynchronous communication between the CHW and
caregiver, which KDHRC hypothesizes will build trust and overcome hesitancy to ask for support. Once
complete, KDHRC will conduct a well-powered and methodologically strong two-arm randomized controlled
trial to explore stage 2 of the model – the impact of receiving outreach from IN-HOME trained CHWs on
caregiver outcomes.
The need for IN-HOME is substantial. As the population of older adults continues to increase, there is a
growing need for informal caregiver support for the 90 percent of the older adults who prefer to stay in their
own homes instead of receiving institutionalized care. Almost 40 percent of all informal caregivers are male,
and minorities are more likely to be long-time caregivers and are at higher risk for caregiver burden, stress, and
burnout. But while there are millions of minority male caregivers, current resources, and even the national
discourse, have neglected this important segment of the caregiver population. CHWs are in a strategic position
to empower male caregivers, and IN-HOME will be a powerful addition to the public health arsenal to address
this challenge.

Public health relevance
Informal caregivers of older adults aging in place are at a substantial risk of negative emotional, mental, physical health implications, and increased mortality because of prolonged distress, intense physical demands, and sense of loss that affect caregivers’ physiological and psychological functioning. Among all caregivers, minorities are more likely to be long-time caregivers and are at higher risk for caregiver burden, stress, and burnout – and while more men in general, and Black and Latino men specifically, are full time caregivers for older adults, there are few resources to support this particularly at-risk group. We will finalize a culturally competent, online professional development course for community health workers to support male minority caregivers, then explore the impact of trained CHW outreach on caregiver knowledge, skills, and health, and wellbeing.